Maintenance and Enhancement of ISO/IEC 17025 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories

Commonwealth of Virginia Division of Consolidated Laboratory Services (DCLS) Maintenance and Enhancement of ISO/IEC 17025 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories RFA-FD-17-010 SF424: Other Project Information Project Summary: DCLS is the public health laboratory for the Commonwealth of Virginia and offers a wide variety of laboratory testing services for state and federal agencies, local governments and other states in support of public health, environmental protection and emergency response. DCLS provides surveillance and emergency response testing of food samples for the Virginia Department of Agriculture and Consumer Services (VDACS) Food Safety Program by offering nearly comprehensive testing of food samples by microbiology, chemistry and radiochemical methods. DCLS obtained ISO/IEC 17025 accreditation in January 2017 for five food testing methods (three microbiology and two chemistry methods) and proposes to maintain and expand this accreditation scope to include up to two additional methods and one new technology. DCLS? long term goal is to integrate ISO/IEC standards for all methodologies for food safety testing required by the VDACS manufactured food regulatory program. DCLS proposes to analyze manufactured food surveillance samples by ISO/IEC scope methods as a continuation of the sampling agreement currently established with the VDACS Food Safety Program for which high risk samples are targeted from retail and manufacturing establishments. DCLS is a participating partner in the FDA CFSAN GenomeTrakr Network and proposes to further enhance the GenomeTrakr Network pathogen databases by sharing genome sequences of 400 pathogen isolates from food, environmental and animal sources annually. The genomic information made available through the GenomeTrakr Network can identify food products potentially associated with an outbreak, assist with traceback of contaminated food ingredients and compliance monitoring of sites with previous pathogen contamination issues.

Public health relevance
Commonwealth of Virginia Division of Consolidated Laboratory Services (DCLS) Maintenance and Enhancement of ISO/IEC 17025 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories RFA-FD-17-010 SF424: Other Project Information Project Narrative: DCLS seeks to provide high-quality and defensible data for Virginia and federal agency partners. DCLS seeks to enhance the current ISO/IEC accreditation scope to include priority analytes, including bacterial pathogens, filth and chemical pesticides capable of causing significant harm to the citizens of Virginia and the United States. Through sequencing bacterial pathogens from food sources, DCLS will add to the diversity and content of genome databases used for high-resolution foodborne outbreak source attribution and industry compliance tracking to ultimately improve the capacity of public health officials to detect and respond to food safety hazards.